Cell specific gene expression in the genesis and dispersal of Vibrio cholerae biofilm

Vibrio cholerae causes the waterborne diarrheal disease, cholera, with annual fatality rates
reaching 120,000 worldwide. Cholera outbreaks are common after natural disasters including
earthquakes, storms, and floods where a reservoir of V. cholerae persists as aquatic biofilms
(surface-attached microbial communities that are composed of microorganisms and a matrix
composed of extra-polymeric substances, such as exopolysaccharides, proteins, and nucleic
acids) found in sewage contaminated waters. Biofilms are complex structures consisting of cells
which have distinct functions. The goal of this project is to identify the cellular states occupied by
different V. cholerae cell populations within biofilms. We will determine how different cell types
organize in 3-dimentional space during biofilm structure formation and how specific cells bring
about the dispersal of biofilm in response to host signals present at the onset of infection. We will
first measure the single cell transcriptome of thousands of single V. cholerae cells grown in
laboratory culture media in either planktonic state or a biofilm using a microfluidic bacterial single-
cell RNAseq assay we recently developed. We will compare the level of cell-to-cell heterogeneity
in biofilm vs planktonic state at different times of growth. This data will identify the physiological
states in which bacteria exist within the biofilm. After examination of the inherent cell-cell
heterogeneity within biofilms we will use a fluorescence microscopy approach to determine the
spatial arrangement of each cell-type within the 3-dimentional structure of biofilms. During V.
cholerae colonization of the human GI tract ingested biofilms disperse into single cells upon
contact with host-secreted bile acids. After we characterize the early formation, organization and
maturation of biofilms we will next determine which cellular changes occur during biofilm dispersal
in a model that utilizes specific bile-acids and temperature for biofilm dispersal. Our data will
provide the first transcriptome-wide measurements of the transcriptional plasticity of V. cholerae
in biofilms, their natural infective reservoir, and will be useful in identifying states associated with
the onset of infection.

Public health relevance
Cholera outbreaks can cause high morbidity and mortality in communities dealing with natural disasters where water supplies can be contaminated by sewage. In these situations, Vibrio cholerae bacteria can form aquatic biofilms, biological structures in which bacteria organize and persist to infect large numbers of individuals. This proposal will use new methods to characterize the way in which different cell-types are organized to produce persistent and infectious V. cholerae biofilms.